Mechanisms underlying combination therapy mobilizing NK cells

Checkpoint therapy is remarkably effective against many malignancies that were previously devoid of effective
treatment options. Nevertheless, even for the types of cancer where it is effective, many patients do not respond,
or their cancers recur. The therapy is ineffective in many other types of cancer. Evidence has accumulated that
ineffective checkpoint therapy is often due to either the dearth of neoantigens in a given type or example of
cancer, or acquired resistance to therapy, which is frequently due to loss of MHC I antigen presentation or
neoantigen expression. Therapeutics that mobilize NK cells may dramatically complement T cell mediated anti-
tumor mechanisms, because NK cells do not depend on neoantigens, and are especially effective against MHC-
deficient tumors, which arise during checkpoint therapy. Preliminary data show that innate agonists, such as a
STING agonist, dramatically synergize with an IL-2 superkine called H9-MSA, leading to NK-dependent indefinite
long term tumor free survival in mice with established MHC I-deficient tumors, including the cold B16-B2m-/-
model and the MC-38-B2m-/- model, which were otherwise refractory to each therapy alone. Strikingly, this
therapy combination was also effective in “curing” mice of MHC I+ B16 tumors, mediated by CD8 T cells, and
primary methylcholanthrene (MCA)-induced sarcomas, a highly stringent autochthonous model of cancer that
was also refractory to checkpoint therapy, where both T cells and NK cells mediated antitumor effects. In the
latter model, the addition of checkpoint therapy led to long term remissions in ~half the animals. In clinical trials,
STING agonists alone have been disappointing in cancer patients, but our new evidence of great synergy of
STING agonists and IL-2 superkine suggests that the combination may have great potential for applications in
human cancer therapy. We will interrogate the mechanisms of synergistic efficacy of this combination, including
whether STING agonist, via IFN, protects NK cells from fratricide induced by the superkine, or cooperatively
prevents NK desensitization. We will further address the impact of checkpoint therapy on top of or preceding this
therapy combination, including understanding how T cells and NK cells cooperate. We will model the acquired
resistance of tumors to checkpoint therapy via selection of MHC-loss variants expression in a tumor transfer
model. Finally, we will employ the MCA sarcoma model undergoing therapy to test the roles of T cells in selecting
MHC I deficient or other NK sensitive variants, and of NK cells in potentially selecting T cell sensitive variants.
The culmination of these studies will provide a strong basis for understanding and applying this form of
combination therapy in human patients with cancer.

Public health relevance
My laboratory is dedicated to developing new methods of immunotherapy for cancer. We have developed methods to superactivate natural killer cells, and prevent them from becoming inactivated, which are highly promising for treating malignancies that are not controlled well by T cell therapies. The approach also activates anti-tumor T cell responses potently. The data suggest that these therapies work in concert with existing (checkpoint) therapies to provide better tumor control. Our plan is to dissect the mechanisms that underlie the effectiveness of the therapy. Furthermore, we will systematically investigate these approaches in mouse models of cancer as preliminary evidence for testing in human patients. These studies will provide new avenues of therapy for patients with treatment-resistant cancer. 1